A Community Knowledgebase to Evaluate Host-Microbial Salivary Proteomics

ABSTRACT An important goal of the oral, dental and craniofacial biology research community is to understand how host and microbes interactions work within each niche and disseminate the data widely. Because of saliva’s complexity, biofluid-based proteomic evaluations provide new resources and knowledge related to the composition and function. The Human Salivary Proteome Wiki (HSP Wiki) was developed with the aim to allow the oral research community to expand the available information. Yet, to achieve real advance and capture the molecular complexity of saliva, novel resources must be put into place. The investigations outlined on this proposal are poised to ultimately provide novel information on host-microbial interactions in the oral cavity by harnessing information gained from the salivary proteome. The Long-Term Goal of this project is to establish the resources and develop new tools to allow continuity in salivary research for both scientific discovery and diagnostic applications. For that purpose, the First Aim will transfer and provide the research community with a functional and curated database that is reliable and innovative to evaluate proteomic studies. As a community resource for depositing, annotating, and studying salivary proteomic data, the HSP Wiki platform has a goal to provide access to of an array of information and analytic tools. The Second Aim will implement a novel computational infrastructure for salivary proteomic datasets that includes visual analytics, faster processing, and efficient measures of success. The Third Aim will utilize the Human Oral Microbiome Database (HOMD) to provide web- accessible taxonomic, genomic and proteomic information and analysis tools for the research community. Because it is currently being expanded to include information on the viruses (phages) that infect the oral bacteria and archaea, we aim to integrate proteome data from HOMD into the HSP Wiki database. Here, we aim to perform a series of studies to determine how the salivary proteome identification coverage is increased by expanding the proteome reference library from just human proteins to those derived from oral bacteria, archaea and phages. The expected outcome of HSP and HOMD integration will provide the research community with a greatly enhanced online resource for examining the composition of the salivary proteome and its impact on human health and disease. Broad dissemination of this project and increased use of the HSP Wiki will catalyze discovery, enhance rigor, and will eventually increase chances of translation towards precision medicine and diagnostic applications of saliva-derived biomarkers.

Public health relevance
PROJECT NARRATIVE Saliva is a biofluid essential to human health and its constituents are relevant to human oral diseases such as caries, periodontal diseases, oral cancers and a suspected role to systemic diseases such as type 2 diabetes, cancers, preterm birth, and autoimmune conditions. The proposed research will provide novel tools, informatic pipelines, and proteomic information related to human health and disease. Based on this information, this project will catalyze increased chances of healthcare professionals to understand, and detect early salivary biomarkers, and prevent diseases with precision.